COMPARATIVE AND DEVELOPMENTAL IMMUNOBIOLOGY

Recent studies have revealed that although the frog, Xenopus, expresses class II molecules throughout larval and adult life, tadpoles of this species do not express detectable class I antigens until they reach metamorphic climax. Hence, the larval frog provides a unique "model of nature" (somewhat akin to humans with the "bare lymphocyte" syndrome) with which to examine the biological roles of class I and class II antigens and class I- and class II-reactive T cells from an immunologic, ontogenetic, and phylogenetic perspective. The major goal of this proposal is to better understand the importance, in Xenopus, of class I antigen expression and anti-class I-reactive and class II-reactive T cells on: 1) lymphocyte-target cell interactions, 2) the establishment of self-tolerance and allotolerance, and 3) the ontogeny of the T cell repertoire. More specifically, I will use in vitro proliferative and cytotoxic assays, skin grafting between larvae and adults, embryonically created thymus/hematopoietic chimeras, and molecular biological techniques to address the following questions: 1. During adult life, do class I and class II gene products serve as target and restriction molecules of cytotoxic T cells? 2. In the absence of class I expression, do tadpoles have class I- restricted and anti-alloclass I-reactive cytotoxic T cells? 3. Do class II molecules serve as restriction elements for both helper and cytotoxic T cells of tadpoles? 4. Is there a relationship between the lack of class I expression and the ease with which tadpoles become tolerant of adult skin allografts (i.e., do class II disparities favor tolerance induction)? 5. If expression of class I molecules can be induced precociously in tadpoles, does this accelerate maturation of anti-class I- reactive T cells and facilitate development of autoimmunity? 6. Does the thymus play a critical role in the acquisition of the T cell repertoire, and when during ontogeny does it play this role? 7. What rearrangements of T cell receptor genes occur during ontogeny?